Global Health Equity Scholars Program - D43 Fogarty Training

Project Summary/Abstract:
We propose to continue our global health research training program called Global Health Equity
Scholars (GHES) program designed to create a new community of researchers, educators, and
professionals prepared to address new and emerging global health challenges. We will build on the
last 4 years of this training program to create a cadre of new researchers who can dedicate their
research career to address the health problems that arise out of inequity of human conditions
prevalent in informal human settlements that the United Nations has defined as slums. Rather than
addressing one disease at a time, we propose to provide a comprehensive, multidisciplinary and
integrated approach to deal with slum health issues, developed over many years by various
participating faculty members of this program. This program will be comprised of 4 US partner
institutions (Consortium) that include University of California at Berkeley, Yale University, Stanford
University, and Florida International University, each led by a leader in global health research with
many years of collaborative relationship among themselves. Together, core training faculty members
(mentors) of these institutions currently conduct research at one of 31 sites in 23 countries,
representing Africa, Latin America, the Caribbean, South and Southeast Asia, Middle East, Eastern
Europe, and Oceania. The training program will address a wide range of health research topics
including emerging and high-consequence infectious diseases, non-communicable diseases (NCD),
women's health, environmental health, mental health, interpersonal violence, substance abuse, and
the interaction of all of these health issues within the framework of slum health. Training will target
US postdoctoral fellows and pre-doctoral students, as well as low and middle-income country (LMIC)
postdoctoral fellows. They will undergo 8-12-month of training at one of the 23 countries under
supervision of the Consortium and their collaborating LMIC mentors. They will be provided with both
research and career mentorship throughout the course of their training and tracked for career
development after completion of their GHES-supported research work. Thus, through this training
program, we will introduce to the trainees one major and important aspect of global health research
(slum health research) and provide an opportunity for them to become experts in this new global
health discipline.

Public health relevance
PROJECT NARRATIVE This application proposes to establish a training program called Global Health Equity Scholars program comprised of four institutions—University of California at Berkeley, Yale University, Stanford University, and Florida International University (called Consortium)—designed to train US postdoctoral fellows and upper division pre-doctoral students, as well as postdoctoral fellows from low and middle- income countries (LMIC) to help them launch a career in global health research. The program will emphasize multidisciplinary and integrated approach to training through participation in supervised research projects of the Consortium investigators at 31 research sites in 23 countries focused around the theme of informal human settlements. We wish to create a new group of experts in a new branch of global health research that deals with adverse health outcomes that arise out of inequity.